Key sentinel roles of IFN-gamma production by microglia to orchestrate the innate and T cell-mediated protective immunity to prevent reactivation of cerebral Toxoplasma infection

Reactivation of chronic infection with Toxoplasma gondii in immunocompromised individuals results in the development of life-threatening toxoplasmic encephalitis (TE). To improve prevention and treatment of TE, it is critical to define the mechanisms of the protective immunity to control T. gondii in the brain. Our recent study using bone marrow chimeric mice uncovered that IFN-γ production by brain-resident cells is crucial for activating the protective innate immunity to limit T. gondii growth and for recruiting and activating immune T cells in the brain to prevent reactivation of the infection. Our studies also identified that microglia (resident macrophages in the brain parenchyma) produce IFN-γ in response to T. gondii growth in the brain. These evidences led us to hypothesize that IFN-γ production by microglia is a key sentinel mechanism of the brain to provide the early stage innate defense and promptly activate T cell-mediated protective immunity to prevent reactivation of T. gondii infection. In Aim 1, we will employ mice deficient in IFN-γ only in the microglia among brain-resident cells and reveal the key sentinel role of microglial IFN-γ to activate the cerebral innate immunity to limit reactivation of T. gondii infection. We will also determine the role of dense granule protein 6 of T. gondii as a major target of microglia to detect tachyzoite proliferation in the brain and activate their IFN-γ production. Aim 2 is to illustrate the crucial protective role of microglial IFN-γ to induce cerebral expression of CXCL9 to facilitate recruitment of immune T cells into the brain. We will also identify the importance of microglial IFN-γ to upregulate an expression of MHC class I and II molecules in brain-resident cell populations, which is required for presenting T. gondii antigens to the T cells recruited into the brain for their activation. In regard to the T cell population to prevent TE, we previously showed that CD8+ T cells alone in combination with cerebral innate IFN-γ production are able to prevent reactivation of T. gondii infection. CD8+ T cells recognize target antigens presented by the MHC class I molecules, and different MHC class I molecules present different antigen epitopes to CD8+ T cells. Therefore, T. gondii antigens that efficiently activate the protective CD8+ T cells most likely differ depending on the MHC class I molecules expressed in each individual. There are three MHC class class I supermotifs, HLA-A2, -A3, and -B7, which encompass 90% of the human population. Aim 3 is to identify the T. gondii molecules that most efficiently stimulate IFN-γ-producing CD8+ T cells capable of preventing TE specifically for each of these three MHC class I supermotifs. We will also confirm an efficiency of the immunization with the identified T. gondii molecules to activate CD8+ T cells capable of preventing TE using transgenic mice expressing these human MHC molecules. These studies will uncover the critical cerebral immune system coordinated by microglial IFN-γ and shed light on the molecular mechanisms involved in the immune coordination and T cell activation. The studies will also provide the basis for precision vaccines for each of the three MHC class I supermotifs to activate the protective CD8+ T cells to prevent TE.

Public health relevance
Reactivation of chronic infection with Toxoplasma gondii causes life-threatening toxoplasmic encephalitis (TE) in immunocompromised individuals such as those with AIDS. The proposed studies aim to elucidate the mechanisms by which IFN-γ produced by microglia (one of the brain-resident cell population) coordinates the protective immunity to prevent TE, and to identify the T. gondii molecules that most efficiently activate the microglial IFN-γ production and the protective CD8+ T cells capable of preventing TE, respectively. These studies will generate the information crucial for understanding the mechanisms of the protective immunity to prevent TE and for developing a vaccine to activate the protective CD8+ T cells capable of preventing TE even when CD4+ T cell counts become low due to AIDS.